Fibrocytes: A novel cell population promoting obesity-induced breast tumor desmoplasia

PROJECT ABSTRACT
Obesity rates are rising worldwide. Obesity is a significant risk factor for development of breast cancer, and
obese breast cancer patients have a worse prognosis. Breast tumors from obese patients have increased
desmoplasia, with significantly more smooth muscle actin (SMA) positive cells, a marker for myofibroblasts,
within tumors. Obesity induces a state of chronic, macrophage-driven inflammation. It is not understood how
inflammation within the obese breast contributes to adipose tissue fibrosis and tumor desmoplasia. In obesity,
myeloid progenitor cells are significantly increased within bone marrow. Fibrocytes, a myeloid lineage cell type
with characteristics of both macrophages and myofibroblasts, are derived from myeloid progenitor cells and are
increased in chronic inflammatory and fibrotic diseases. The long-term goal is to understand how the systemic
inflammatory conditions of obesity contribute to fibrotic tumors. The rationale is that tumor fibrosis is associated
with more aggressive tumors, and understanding this inflammatory microenvironment will lead to discoveries of
much needed therapeutic targets for obese cancer patients. The overall objective of this proposal is to identify
how obesity increases fibrocytes to enhance collagen deposition within tumors, and how weight loss intervention
reverses these effects of obesity. The central hypothesis is that obesity reversibly increases myeloid progenitor
cells and fibrocytes within the bone marrow and mammary gland, respectively, leading to an increase in collagen
deposition within tumors. This hypothesis will be tested in three specific aims: 1) To identify how obesity-induced
fibrocytes contribute to mammary tumor stroma; 2) To elucidate how obesity-induced fibrocytes enhance fibrosis
during tumor growth; 3) To examine how weight loss decreases fibrocytes within the normal mammary gland
and mammary tumors, resulting in reduced fibrosis. A diet-induced mouse model of obesity and trp53-/-
mammary tumor cell xenografts will be utilized to test these aims. Myeloid progenitor cells and monocytes/
macrophages in bone marrow and mammary tumors will be quantified from lean, obese, and weight loss mice
using FACS and flow cytometry. Colony formation from FACS isolated cells will be used to quantify mammary
tumor fibrocytes. Adoptive transfer using FACS isolated GFP-expressing bone marrow cells from obese mice
will be used to examine cell populations responsible for tumor fibrosis. Picrosirius red staining multiplexed with
immunofluorescence will be used to examine collagen deposition in mammary tumors and localize fibrocytes.
This approach is innovative because fibrocytes have not been studied in obesity, and the mechanisms underlying
obesity-induced tumor desmoplasia are not well understood. Identifying how obesity regulates fibrocytes and
tumor fibrosis is important to develop novel therapies to treat the more aggressive tumors observed in obese
cancer patients. Beyond new technical knowledge, the training described provides opportunities to enhance
science communication, networking, and mentorship skills within the collaborative research environment at UW-
Madison. The training plan will help the applicant work toward a career as an independent cancer researcher.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because obesity has become an epidemic in the US, and there is a critical need to understand how obesity and weight loss interventions alter breast tumor growth to develop targeted therapies for obese patients. Thus, the proposed research is relevant to the NCI's mission to help obese women live longer, healthier lives.